Inflammation and Cardiovascular Disease in RA

DESCRIPTION (provided by applicant): Cardiovascular disease (CVD) is a major cause of morbidity and mortality in rheumatoid arthritis (RA). Enhanced rates of incident CV events in RA are evident even before signs and symptoms of arthritis begin, suggesting that RA-specific immune-mediated processes that promote CV risk are activated very early. We hypothesized that genetic risk (present at birth) and/or RA-specific autoantibodies (known to predate clinical symptoms) may convey early risk for coronary artery disease (CAD) and/or heart failure (HF) in RA. Indeed, our preliminary data strongly suggest that RA susceptibility genes (the HLA-DRB1* "shared epitopes") are predictive of more severe subclinical atherosclerosis in RA. Furthermore, RA patients exhibited a markedly lower left ventricular (LV) mass than matched controls, and, among the RA patients, this was highly associated with anti-cyclic citrullinated (- CCP) peptide antibodies. This is in stark contrast to an increase in LV mass that generally precedes clinical HF in the general population, and suggests that HF in RA may progress along different pathways. In pilot studies, we have also observed diffuse sub-endocardial hypoperfusion in the LVs of 3 of 3 patients with active RA, suggesting that myocardial microvascular dysfunction is a key contributor to loss of LV mass. It has been hypothesized that effective treatment of RA may reduce the risk of HF in RA but a major RA therapy [the tumor necrosis factor-1 (TNF- 1) antagonists] appeared to worsen HF in non-RA patients. So far, no studies have directly investigated the effect of TNF antagonists on myocardial structure and function in RA. Our overall hypothesis is that RA-specific immune mechanisms initiate and/or propagate systemic, as well as local (myocardial), inflammation, leading to accelerated atherosclerosis and myocardial dysfunction. We propose the following three specific aims to investigate this hypothesis. Specific Aim 1. In combined (JHU and nonJHU) RA populations, we will evaluate the association of RA susceptibility genes/loci - with a primary focus on the HLA-DRB1 "shared epitope" genes - with the presence and severity of atherosclerosis. Specific Aim 2. In RA patients, we will evaluate the association of RA characteristics (particularly, anti- CCP), myocardial microvascular perfusion, and myocardial inflammation/fibrosis with parameters of LV structure and function. Specific Aim 3. In a prospective pilot study of RA patients without clinical HF, we will evaluate the effect of treatment with TNF antagonists on parameters of LV structure and function, and on myocardial microvascular perfusion and myocardial inflammation/fibrosis over six months. Our preliminary data represent novel findings that could have significant impact on early recognition and management of RA-associated CV disease. A better understanding of RA related factors that initiate and/or accelerate CAD and HF in RA, and that identify subgroups at highest risk, and of the effect of treatment on these risks, are crucial in order to develop targeted interventions and reduce CV associated morbidity and mortality. PUBLIC HEALTH RELEVANCE: In the proposed studies, we will investigate several hypotheses that might help to explain why individuals with rheumatoid arthritis (RA) are at much higher risk of dying from heart attacks and heart failure than individuals without RA. We propose that genes that make people susceptible to getting RA, and antibodies against certain proteins that are typically found in the blood of RA patients, make them susceptible to developing hardening of the arteries and weakened heart muscle, respectively. In this study, we will also investigate the safety of a major class of drugs for RA - the TNF inhibitors - on the size and pumping ability of the hearts of RA patients, since these drugs have been found to be dangerous in non-RA patients with heart failure.

Public health relevance
The proposed studies, we hypothesize that enhanced systemic and/or local inflammation contributes significantly to the increased risk for cardiovascular events in individuals with rheumatoid arthritis. We will utilize state-of-the art imaging techniques that highlight inflammation both within blood vessels and in the myocardium. In addition, we will examine a genetic risk factor, associated with susceptibility to developing rheumatoid arthritis, to determine whether it also conveys risk for accelerated heart disease.